Cancer Center Support Grant

pecific Aims This project examines the effects of immune checkpoint therapy (ICT) for the treatment of KS. The study includes samples from a clinical trial and a novel correlative assay using scRNA-seq to predict and evaluate responses. We will examine the response to nivolumab in a phase 2 expansion arm of 15 KS patients of our ongoing multicenter AIDS Malignancy Consortium (AMC) study of HIV-1 infected subjects (NCT02408861). The study includes individuals with KS refractory to systemic therapy, who will receive 480 ug of nivolumab every 28 days. Clinical study costs and other correlative studies, e.g. KSHV virus levels in plasma and blood mononuclear cells are supported by the AMC. For correlative studies, we utilize unbiased scRNA-seq with baseline and post2nd cycle biopsies from 5 individuals with greatest response, and 5 non-responders.

Public health relevance
OVERALL: PROJECT NARRATIVE The Alvin J. Siteman Cancer Center (SCC) at Washington University and Barnes-Jewish Hospital is a NCI designated Comprehensive Cancer Center whose mission is to prevent cancer in the community and transform cancer patient care through scientific discovery. SCC accomplishes this mission through strong research programs, shared resource support, education and training, pilot funding programs, and community outreach. The translational research and scientific discovery facilitated by our seven multidisciplinary research programs and 10 shared resources (11th requested in this application) is driven by the needs of patients in our 82-county catchment area throughout Missouri and southern lllinois.